A Research Reboot of Tuberculosis on the Keystone Symposia 50th Anniversary

ABSTRACT
Support is requested for a Keystone Symposia conference entitled A Research Reboot of Tuberculosis on the
Keystone Symposia 50th Anniversary, organized by Drs. Joseph Keane, Shabaana A. Khader, Thomas J.
Scriba and Alan Sher. The conference will be held in Breckenridge, Colorado from January 23-26, 2022.
Tuberculosis (TB) is an ancient scourge of mankind that still to this day remains a leading cause of death by a
single infectious agent only surpassed in its global mortality by the current COVID-19 coronavirus pandemic.
Nevertheless, with the advent of effective antibiotics and improved public health measures, in the middle of the
20th century, TB had substantially declined and was thought by many to be destined for eradication. By 1972,
the year of the founding of the Keystone Symposia, this conclusion was quashed by expanding caseloads in
New York City and other urban areas and later by the devastating impact of HIV-coinfection. This major
disease re-emergence stimulated a new era of intense research aimed at conquering TB. This symposium will
showcase the outstanding breakthroughs of TB researchers over the last 50 years, while highlighting current
advances in the field. Special attention will be given to the results of the latest promising vaccine trials, as well
the discovery and implementation of improved antibiotic regimens. This program will also emphasize the
exciting advances in our basic understanding of the host-pathogen interaction, and in particular in the area of
immunometabolism, that are leading to the identification of new host-directed treatment targets. Keynote
lectures will overview the major achievements, while exploring the current state of global tuberculosis, as well
as the impact of viral pandemics on tuberculosis research and control. Taken together, the program will propel
the field forward toward achievement of our ultimate goal of TB eradication.

Public health relevance
PROJECT NARRATIVE The backdrop of the unprecedented efforts that have been mobilized to control the COVID-19 pandemic provides a blueprint for activism, commitment and collaboration needed to control TB, the infectious disease that held the highest global mortality rate until 2020. This conference is designed to increase communication and collaboration between investigators from diverse backgrounds, provide lessons from the last 50 years of TB research, and highlight recent advances that demonstrate the particular promise that research and innovation can indeed lead to more effective control of the devastating TB epidemic. This conference will contribute to increasing interdisciplinary communication and collaboration, to optimize bidirectional flow of information that will positively impact the field of TB research and the lives of millions across the globe.